Precision Brain Health Monitoring for Alzheimer's Disease Risk Detection in the Framingham Study

Project Summary
This supplement seeks to extend the data collection of lens amyloid and smartphone cognitive data to include
participants who are Hispanic-Latino/LatinX descent. These data will offset the limited racial/ethnic
heterogeneity of the FHS cohort, which is largely non-Hispanic White. The Rio Grande site from which
participants will be invited to participate is 99% Hispanic-Latino/LatinX. An estimated 25% of the elderly
population in this area are diagnosed with AD dementia and there is concern that this is an underestimate
because of income and limited healthcare insurance. The first aim will conduct an ocular scan that provides
an Aß biomarker of AD measured in the lens to characterize Aβ burden in a community-based population
of Hispanic-Latino/LatinX descent whose age ranges overlap with that of the FHS cohort. The second
aim includes using smartphone applications to collect 1 year of longitudinal cognitive metrics from
participants who are of Hispanic-Latino/LatinX descent that can be combined with 1 year of longitudinal
cognitive metrics from the FHS cohort so that characterization results are more generalizable. Currently
the Framingham Heart Study cohort from which the lens amyloid and digital cognitive assessment are to be
collected is estimated to be 3,375 of which 131 are projected to be of Hispanic/Latino/LatinX descent. This is
well under the 18.7% of the U.S. population that is comprised of people from this ethnic/racial group. To collect
data is that is appropriately representative (e.g., 18.7%) will require collecting data from an additional 500
participants from the Rio Grande site.

Public health relevance
Project Narrative The primary objective of this supplement request is to extend the original plan of collecting lens amyloid and digital cognitive assessments to off-set the lack of racial/ethnic diversity of the Framingham Heart Study cohort, which is primarily comprised of people who are non-Hispanic White. This supplement request will collect additional data from 500 participants who are from the Hispanic/Latino/LatinX community.